Using digital photovoice to explore the relationships between social media content and suicidality among transgender adolescents

Project Summary/Abstract
Social media has a complex influence on mental health. It can contribute to bullying and harassment, which
may result in loneliness, depression, and suicidality, but it can also be helpful, by fostering social connections
and offering resources; these influences may both harm and benefit the same individuals. Transgender youth
is a highly vulnerable group, who is often subjected to bullying and are far higher risk for self-harm and
suicidality than cisgender youth. An increasing number of trans adolescents are using social media. In this
proposed study, we intend to understand the effect of emotionally laden social media content consumed by
trans and gender non-binary adolescents (TGNB) (ages 15 - 20) and its connection to suicidality. We focus on
high schoolers and emerging adults, as suicidality rates in this group of social media users is higher than
among middle-schooler social media users. Existing research is largely cross-sectional, correlational,
retrospective, and focuses on “posts” (content individuals produce themselves), which limits its utility in
understanding fully the impact of social media on adolescents, for three reasons. First, most social media use
consists of passive consumption, not active posting. Second, it is important to gain in-the-moment information
about emotions individuals experience when a particularly salient social media content is consumed. Finally,
retrospective and correlational designs lack the capacity to generate or test predictive models. To address
these gaps, our study will be prospective and longitudinal, focusing on passive social media consumption, and
deeply individualized and person-centered. We will adapt `Photovoice' (PV), a commonly-used community-
based participatory research method that is considered an excellent method for understanding the
perspectives of individuals, including those from underrepresented populations. We will use a previously
piloted S.T.A.R (Screen Tag and React) app, with which participants will be able to capture screenshots of
anything they see on any social media platform, indicate their emotional reaction to that content, and upload
these on a secure cloud server. Participants will be recruited largely from social media groups for TGNB
populations and their parents. Participants will use the S.T.A.R. app for 8 weeks, undergo an interview to better
understand the images they capture, and then use it for another 8 weeks so that prediction models we develop
could be evaluated. Thus, with this study, we will be able to understand whether, for each TGNB adolescent,
the unique patterns of positive/negative emotions elicited by social media are associated with patterns in
weekly assessment of suicidality. We will also be able to determine whether specific types of social media
content are associated with changes in suicidality scores for transgender adolescents. Finally, we will be able
to create a prediction model to map social media content types and related emotions to predict suicidality.

Public health relevance
Narrative Transgender and nonbinary (TGNB) youth are at far greater risk for suicide than their cisgender peers, and past research suggested that social media use may increase this risk. This person-centered, longitudinal study will use an adapted digital Photovoice method to better understand the relationship between social media consumption and suicidality. TGNB adolescents (ages 15-20) will use an app to take screenshots of emotionally charged social media content and label them with specific emotions; we analyze the data to understand the the relationship between social media consumption and suicidality.